IGF::OT::IGF:The Scripps Research Institute. Task Order 3 (HHSN275201500006I/HHSN27500003)."Production and Distribution of Investigational Ghrelin Vaccines--Ghrelin Vaccine Against Rat Hormone. 09/21/

alcohol